Personalized care for prenatal stress reduction and preterm birth prevention

PROJECT ABSTRACT
This project addresses the critical barrier of solutions for preterm birth (PTB) by deploying a deploying
a novel, personalized, comprehensive 3-tier PTB prevention program (UNC PTBCARE+) to reduce
perinatal stress. There are significant PTB disparities; Black pregnant patients are 49% more likely to deliver
preterm, have a higher risk of PTB at earlier gestational ages, report higher perceived stress, and have higher
allostatic loads compared to patients of other races. UNC PTBCARE+ addresses stress and related mechanistic
underpinnings of PTB. Our long-term goal is to refine and widely deploy an evidence-based intervention to
mitigate stress during pregnancy and reduce PTB. The objective is to test, in a randomized controlled trial that
will enroll 1,509 pregnant patients, whether our UNC PTBCARE+ program that provides a specific stress
reduction toolkit and a PTB Care Coordinator (Tier 1, all patients randomized to UNC PTBCARE+), Enhanced
Psychosocial support (Tier 2a level support, subset of patients who screen positive at randomization), Financial
support (Tier 2b level support, subset of patients who screen positive at randomization), or both (Tier 3 level
support) is associated with stress reduction (assessed subjectively by validated surveys and objectively by
biomarkers), and PTB <35 weeks. Further, we will examine which interventions are most helpful, and will
evaluate whether results vary by race. Our central hypothesis is that enrollment in our personalized,
comprehensive PTB care program (UNC PTBCARE+) is associated with reduced stress, stress-related
gene expression, allostatic load, and rates of PTB <35 weeks. We further hypothesize that UNC PTBCARE+
will most benefit non-White patients due to racism-associated stress, and that biologic analyses will provide key
objective insight into the mechanisms underlying stress-related PTB and the impact of the intervention. This
hypothesis is based upon our preliminary data indicating: (a) pregnant patients at UNC at high risk for PTB have
high rates of stress and life stressors (e.g., financial insecurity, extreme racism), (b) biologic stress markers
including gene transcript levels differ by PTB status in mid-pregnancy blood, (c) reduced stress among patients
receiving specialty PTB prenatal care in a NC cohort. Building upon our prior work and that of others, this exciting
proposal will identify which aspects of the UNC PTBCARE+ program are most critical for stress-related PTB
reduction. We test our hypothesis through the following aims: Aim 1- Evaluate the effects of the UNC PTBCARE+
program on perceived stress and resilience in pregnant patients at high risk for PTB; Aim 2- Quantify the extent
to which the UNC PTBCARE+ program is associated with improved biologic stress measures during pregnancy;
Aim 3- Determine the effects of the UNC PTBCARE+ program on PTB <35 weeks. This study provides
tangible, personalized solutions to the major public health problem of PTB and carries enormous
potential to provide generalizable, low-risk strategies to reduce PTB and PTB related disparities.

Public health relevance
PROJECT NARRATIVE The proposed novel research is relevant to public health as it addresses the critical barrier of solutions for preterm birth by deploying a deploying a novel, personalized, comprehensive 3-tier preterm birth prevention program (UNC PTBCARE+) to reduce perinatal stress, preterm birth, and related disparities. Herein, we propose to test this novel solution-oriented care program by recruiting 1,509 patients to a randomized controlled trial of usual care vs. comprehensive and multifaceted prematurity care. This project is directly in line with the mission, vision, and strategic priorities of the NIMHD by applying evidence-based, personalized solutions to reduce preterm birth disparities and analyze whether the UNC PTBCARE+ program is most effective for Black women because of high rates of racism-related stress.